Development and Testing of the Healthcare Empowerment and Advocacy for Recovery from Trafficking (HEART) Intervention for Syringe Service Programs

PROJECT SUMMARY
Sex trafficking, opioid crisis, and HIV epidemic are intersecting public health emergencies. Data show that 15% of human
trafficking victims in the U.S. have addiction induced or exploited as a means of control—81% of these victims are
women experiencing sex trafficking (defined as involuntary or underage entry into sex work). History of sex trafficking
among sex workers is associated with 11x greater odds of having HIV, with prevalence of HIV among survivors of sex
trafficking as high as 38%. Elevated risk for HIV is accounted for by higher client volume, rates of forced non-condom
use, physical and sexual violence, and injection drug use (IDU) and higher risk IDU practices (e.g., syringe sharing).
People with experiences of sex trafficking are an important population for ending the HIV epidemic yet have been left
behind by current national efforts. We propose that syringe service programs (SSPs) are a novel site for engaging women
who have experience with or are vulnerable to sex trafficking. Decades of research has highlighted the effectiveness of
SSPs in HIV prevention. In this R34 application, we will develop and test novel and innovative peer-delivered brief
intervention to engage women with experiences of sex trafficking and women vulnerable to sex trafficking into
comprehensive care services, including HIV, SUD, and other health (e.g., mental) and social (e.g., legal) services by (1)
providing low barrier access to care in a non-stigmatizing setting (SSPs); (2) using peer delivery with techniques of
motivational interviewing to increase self-efficacy and empowerment; (3) offering trauma-informed and gender-sensitive
integrated harm reduction and addiction services (e.g., PrEP, MOUD, naloxone); (4) providing education and safety
planning for sex trafficking and commercial sex work from a harm reduction perspective; (5) and offering women-specific
reproductive health services (e.g., contraception). Using the human-centered Discover, Design and Build, and Test model
and the Stop Observe Ask and Respond (SOAR) framework for addressing human trafficking, we will co-create the
Healthcare Empowerment and Advocacy for Recovery from Trafficking (HEART) intervention with end users of the
intervention (e.g., SSP staff) and women with experience of sex trafficking. The specific aims of the study are: Aim 1. (a)
Develop HEART intervention components and (b) identify implementation determinants for implementing HEART
within SSPs. Aim 2. Examine the feasibility and acceptability of the HEART intervention to improve HIV and SUD
prevention and treatment uptake (primary outcomes). Aim 3. Document factors relevant to implementation and
sustainment to inform a full-scale randomized control trial of the HEART intervention at SSPs following the RE-
AIM/PRISM frameworks. Findings will provide critical data on the prevalence of sex-trafficking and sex trafficking risk
among an SSP population and will position us to apply for an R01 to conduct a formal evaluation of the effectiveness of
the HEART intervention in mitigating the ongoing HIV epidemic in this population that has been left behind in the
advances for HIV prevention and treatment. Based on our team’s track record at implementation of novel interventions in
an SSP setting, the HEART intervention could be a critical step toward Ending the HIV Epidemic in this high incidence
population.

Public health relevance
PROJECT NARRATIVE Sex trafficking, opioid crisis, and HIV epidemic are intersecting public health emergencies. Given the high rates of injection drug use and HIV among women with experiences of sex trafficking, we propose that syringe service programs are a novel site for engaging women histories of and vulnerability to sex trafficking into HIV, substance use, and other health and social services. We will develop and test the Healthcare Empowerment and Advocacy for Recovery from Trafficking (HEART) intervention using a human-centered and implementation science approach, which will be a critical step toward Ending the HIV Epidemic in this high incidence population